Immunometabolic consequences of alcohol-induced mesenteric lymphatic dyshomeostasis

Abstract
The primary purpose of this Ruth L. Kirschstein NRSA F30 application is to provide the groundwork that will
prepare the applicant for an academic medical career. Much of the applicant’s career development will come
from work in alcohol comorbidity-related research. Alcohol is the most abused substance in the United States
with about one-quarter of the adult population partaking in heavy and/or binge drinking. Chronic alcohol
consumption also disrupts glucose homeostasis and is associated with the development of insulin resistance.
The immune system plays a comprehensive and understated role in adipose tissue and systemic metabolism
surveilling and responding to specific metabolic signals through a set of processes termed immunometabolism.
Results from our previous studies suggest that alcohol-induced mesenteric lymphatic leakage and subsequent
perilymphatic adipose tissue inflammation may be a primary event in the development of systemic
immunometabolic dysregulation seen in chronic alcohol use. Previously our lab has demonstrated that chronic
alcohol induced lymphatic leakage, increased CD3+ and CD4+ T cells, fTregs, and IL-6 in PLAT. Our studies
have also shown that chronic alcohol led to decreased insulin-stimulated glucose uptake in PLAT. We
speculate that cells or molecules leaking from lymphatic vessels into PLAT stimulate fTreg expansion and lead
to PLAT metabolic dysregulation. Taken together, published and preliminary data support the hypothesis that
lymph contents from alcohol-treated animals disrupt PLAT immune and metabolic homeostasis
through fTreg expansion. The proposed study will employ a wide variety of techniques to test the hypothesis
using three specific aims: (1) Lymph from alcohol-treated animals will expand FOXP3+ fTregs in naïve PLAT
explants via IL33/ST2 signaling pathway, (2) alcohol-induced fTreg expansion contributes to metabolic
dysregulation in PLAT, and (3) alcohol-induced PLAT metabolic dysregulation is associated with systemic
metabolic consequences. Findings from the proposed studies will provide insight on the deleterious effects of
alcohol-associated lymph leakage and how its constituents impact PLAT immune cell milieu, specifically
fTregs, contributing to development of PLAT IR and potentially systemic IR. With a strong mentoring team
committed to developing a well-rounded physician scientist, completion of the proposed training plan will
ensure that the applicant is ready to embark on a career in academic medicine.

Public health relevance
Narrative This NRSA F30 fellowship will provide an invaluable training opportunity for a future physician scientist as she develops into an emerging leader in immunology related research. The proposed studies will investigate the role of lymph contents from alcohol-treated animals in PLAT fTreg expansion and subsequent immune and metabolic dysregulation. Findings from this study will further our understanding of the negative consequences of alcohol-associated lymph leakage and how its constituents impact PLAT immune cell milieu, specifically fTregs, contributing to development of PLAT IR and potentially systemic IR.